CD117-Targeted Radioimmunotherapy with Astatine-211 for Acute Myeloid Leukemia and Myelodysplastic Syndrome

ABSTRACT
Radiolabeled monoclonal antibodies (mAbs) have long been pursued to improve outcomes for patients with
acute myeloid leukemia (AML) and myelodysplastic syndrome (MDS) because neoplastic myeloid cells are
exquisitely sensitive to ionizing radiation. Of particular interest are alpha-particle emitting radionuclides such as
astatine-211 (211At) as they deliver a very high amount of radiation over just a few cell diameters. With this, they
enable highly potent, precise, and efficient target cell kill with minimal off-target toxicity. Given its half-life of 7.2
hours, 211At is ideal for patient application. So far, alpha-emitters have been primarily used with mAbs against
CD45 or CD33 for AML/MDS. However, broad display of these antigens on normal cells, including cells residing
outside the bone marrow space, curtails the anti-tumor efficacy of this approach as it limits how much radiation
can be safely delivered. Moreover, when used to augment HCT, CD45- and CD33-directed
radioimmunotherapies (RITs) need to be given in conjunction with conditioning therapeutics, which by
themselves may have little additional anti-leukemia activity but are necessary to ensure allogeneic hematopoietic
stem cell (HSC) engraftment. Relative to RIT targeting CD45 or CD33, we hypothesize that 211At-based RIT
targeting KIT (CD117), a receptor tyrosine kinase that is crucial for proliferation, survival, and differentiation of
hematopoietic cells, will be a more precise approach to effectively treat AML/MDS that entails greatly reduced
risks off-cancer cell toxicities and increased safety when used in the context of allogeneic HCT. Supporting this
notion, 60-90% of patients with AML, and most patients with MDS, express CD117 on their neoplastic cells.
Compared to CD45 or CD33, however, CD117 is expressed on a much more discrete set of normal cells,
rendering it a highly suitable immunotherapeutic target to treat AML/MDS. What makes targeting CD117
particularly attractive for patients with AML or MDS – both disorders for which curative therapeutic strategies
routinely include allogeneic HCT – is that anti-CD117 mAbs efficiently deplete endogenous HSCs and allow
engraftment of allogeneic HSCs in immunodeficient mice. Combined with low-dose irradiation, anti-CD117 mAbs
also provide effective conditioning and durable donor-derived HSC engraftment in immunocompetent animals.
Thus, we envision 211At-CD117 RIT could be used with minimized or no need for additional conditioning
therapeutics to enable allogeneic HCT. Here, we propose to conduct proof-of-principle studies to test the 2 core
components of our hypothesis, namely effective leukemia cell eradiation and facilitation of allogeneic HSC
engraftment, with 211At-CD117 RIT, using suitable immunodeficient and immunocompetent mouse models. Upon
completion of the proposed research, it is our expectation that we will have gained critical insight into how 211At-
labeled anti-CD117 mAbs can be best utilized to treat AML/MDS. This knowledge will guide further development
of this approach for clinical application.

Public health relevance
PROJECT NARRATIVE Even with stem cell transplantation, acute myeloid leukemia (AML) and myelodysplastic syndromes (MDS) are difficult-to-cure blood disorders with currently available treatments. Here, we will develop a new therapy that is based on targeted radiation with an antibody recognizing CD117, a protein found on the cell surface of abnormal blood cells in most patients with AML/MDS, coupled to a short-lived, highly potent radioactive isotope. Because CD117 is also expressed on normal blood stem cells but and not many other cell types, we believe this approach is ideally suited to eradicate AML/MDS cells effectively but also to enable stem cell transplantation with minimal unwanted side effects.